Support of NCI CCR Clinical Research and Bioinformatics

The information technology support program is involved in many aspects of information technology for the NCI Center for Cancer Research (CCR). Projects which we develop and/or maintain include the following: 1) Labmatrix, a tissue research and inventory system for managing both the collection and storage of tissues, as well as data resulting from the research analysis of these tissues. Tissues are from numerous types of cancers and other diseases. 2) iRIS, a protocol lifecycle management system used for all CCR human and animal protocols as well as DCEG Special Studies IRB-managed protocols. 3) CCR Protocol View, a website for NCI and NIH Clinical Center distribution of our clinical trials protocols. 4) Budget Management System, used to allocate funds to CCR principal investigators and core research groups. 5) Redesign and reengineering of the CCR website to a Drupal-based site. 6) CCR Referrals. This provides a standardized way to manage potential clinical trial participants and their medical information as it pertains to being qualified to participate in CCR clinical trials. 7) Section 508 compliance of CCR-managed websites. 8) Scribe, a method of collecting study data directly from study subjects and having that data go through real-time validation and entry into a researcher's data collection system. 9) C2L2, system to manage clinical lab data import into research data systems. 10) Medidata Rave, primary research information management system for phase 1 and 2 trials.